Uncovering the cellular and molecular mechanisms of folic acid fortification in neural tube defects

SUMMARY
The objective of this proposal is to elucidate how folic acid prevents neural tube defects on the cellular and
molecular level, and to develop a platform to functionally validate and test the FA responsiveness of human NTD
candidate genes. Neural tube defects (NTDs) are the second most common congenital abnormality, affecting 6
in 10,000 pregnancies in the United States. Failure to close the neural tube, the precursor to the brain and spinal
cord, is complex disorder resulting from genetic and environmental stressors. Because multiple factors play into
the development of this disorder, it is critical to understand how environmental factors interact with genetics in
the etiology of NTDs. While population-wide folic acid (FA) fortification has reduced the overall NTD rate by 28%
in the US, it remains unclear how folic acid prevents NTDs. My proposal aims to address two hypotheses about
folic acid and neural tube defects. First, I hypothesize that FA contributes to NTD prevention by acting at the cell
movement level as well as inducing transcriptional cascades to compensate for the dysregulated genes. To
uncover whether FA can rescue NT closure by acting at the cellular or molecular level, I will characterize the
cellular movements and transcriptional profiles for the Alx1 mutant mouse model supplemented with FA. The
Alx1 knockout model results in NTDs in 100% of mutant embryos, however prenatal FA supplementation can
reduce the incidence to 13%. The Alx1 mutant is a tractable model to dissect the contribution of FA fortification
to restoring NT closure because NTDs in this model result from dysregulation of a transcription factor and
abnormal cellular movements. We will use imaging-based techniques to characterize cell morphogenesis
processes and scRNA-Seq and scATAC-Seq to identify FA-induced gene expression in the Alx1-null
background. Results from these complimentary studies will inform if FA acts by supporting cellular movements,
inducing transcriptional activity, or a combination. Second, I hypothesize that testing more gene mutations for
FA responsiveness will reveal patterns of gene types that benefit from FA fortification as a prevention strategy.
To address this hypothesis, I will develop a course-based undergraduate research experience (CURE) entitled
The What, the Why, and the How of neural tube defects. The scientific aim of this course will be to functionally
validate candidate human NTD genes of unknown significance in NT closure in chick embryos and test the folic
acid responsiveness. The societal aim of the CURE is to increase the number of relevant research opportunities
for undergraduates while meeting a public health need to screen candidate genes and communicate back to
clinicians and families. I expect screening more candidate genes for NTDs and FA responsiveness will reveal
new high-risk genes and increase our predictive power over the types of dysregulated genes likely responsive
to FA supplementation. Together, the results from this proposal will be important to bolster our understanding of
how FA can prevent NTDs and improve risk assessment of preventative strategies against neural tube defects.

Public health relevance
NARRATIVE Neural tube defects are the second most common birth defect leading to fetal mortality or life-long complications. The risk for developing a neural tube defect can be reduced by increasing folic acid in the diet of pregnant people in some cases, however we cannot predict who this preventative strategy is most beneficial for. The objective of this proposal is to provide insight into how folic acid can support neural tube closure to better inform risk assessment of neural tube defects.